Integrated Networks of Scholars in Global Health Research Training (INSIGHT)

ABSTRACT: This application presents the Integrated Networks of Scholars in Global Health Research
Training (INSIGHT) Program. We have 169 faculty members across multidisciplinary and multi-
institutional consortium working together with 24 LMIC institutions in sub-Saharan Africa, South Asia,
and the Latin America and the Caribbean. A strategic planning process; including a comprehensive
review of our consortium’s role in combatting the global HIV epidemic, emerging and reemerging
infectious diseases, non-communicable diseases, and mental health; was conducted to inform this
proposal. A vision statement encompassing five Themes – Global Impact, Multidisciplinary Science,
Integrated Training with Equal Partnership, Diverse Generation of Global Health Researchers, and Highly
Committed Environment– shapes our work. Key innovations strengthening this proposal include
ensuring diversity; leveraging our institutional commitments in global research training; amalgamating
our strong foundations in clinical, behavioral and laboratory science; enacting a participatory monitoring
and evaluation program; and launching emerging leaders. Aim 1 – Create collaborative, interdisciplinary
global health research that integrates cross-institutional pairing of mentors. The research training
“triad” of US mentor, LMIC mentor, and scholar form a long-term training partnership that builds
research capacity of the scholars and the LMIC partner institutions. Outcomes: Robust interdisciplinary
collaboration engendering innovative research driven by integration and equal partnership between our
four universities and LMIC partners. Aim 2 – Provide one-year research training for 105 scholars with
linkage to the Mentorship Triad Paradigm. We will provide training for five yearly cohorts of 15 scholars
(9 US postdocs, 2 US pre-docs, and 4 LMIC post-docs) in global health research, including coursework
and a mentored research practicum. We will leverage institutional commitment of $1.5 million to
support an additional 30 scholars over five years to maximize impact. Outcomes: 90% of scholars
completing training will submit grant proposals and/or publish their research. Aim 3 – Promote and
support diversity, equity and inclusion in global health research training. We will leverage our existing
initiatives and affiliations with Minority Serving Institutions and pipeline programs. This will include
broad outreach to departments, centers, and schools at partner universities; and engaging student
groups and associations of underrepresented populations in global health. Outcomes: 50% of LMIC
scholars will be women and at least 30% of US scholars will be from underrepresented minorities. Aim 4
– Support the transition of scholars into successful and sustainable research careers. We will link
scholar selection to LMIC priorities and research programs. Outcomes: Sustained collaboration between
scholars and INSIGHT consortium researchers for at least five years.

Public health relevance
NARRATIVE The Integrated Networks of Scholars in Global Health Research Training (INSIGHT) consortium formed between the University of Alabama at Birmingham, the Baylor College of Medicine, the University of Maryland Baltimore, and the University of Pittsburgh supports training for the next generation of global health scholars from the US and low- and middle-income countries (LMICs) through mentored research experiences at 24 established partner LMIC institutions across 19 countries in Africa, Asia, and Latin America and the Caribbean. Strong emphases are on a broad range of global health research areas, including combatting the global HIV epidemic and associated co-morbidities, emerging and re-emerging infectious diseases, non-communicable diseases, and mental health.